Development of a hamster model for hepatitis B virus infection

PROJECT SUMMARY
Hepatitis B virus (HBV) has infected more than one-third of the world’s population and that almost 296 million
people are currently living with chronic infection including over 6 million children under the age of five. Each year,
about 1.5 million people become newly infected and 820,000 people die from HBV infection and related
complications. Therapeutics for HBV are available, but they hardly lead to a functional cure for chronic HBV
infection. One of the biggest challenges in developing an HBV cure is the lack of immunocompetent animal
models that are susceptible to HBV infection and support the entire life cycle of HBV. HBV has an extremely
narrow host tropism, determined both by species-specific host cellular viral entry receptor, sodium taurocholate
co-transporting peptide (NTCP), and the host factors needed to support the lifecycle of HBV post viral entry.
HBV transgenic mice do not support the formation of viral covalently closed circular DNA (cccDNA), the bona
fide viral transcription template, via the intracellular cccDNA amplification mechanism; genetically modified mice
carrying human NTCP fail to establish HBV infection due to the failure of de novo cccDNA formation. In search
of other laboratory animal species-derived hepatocytes that may support HBV cccDNA formation, our preliminary
studies demonstrated that Ad-HBV-transduced primary hamster hepatocytes (PHaHs) are capable of supporting
HBV DNA replication and cccDNA formation, and Ad-hNTCP-transduced PHaH cells are susceptible to HBV
infection. Hence, the objective of this project is to establish a novel Syrian hamster (Mesocricetus auratus) model
that is tractable, fully immunocompetent, and highly susceptible for HBV infection. To this end, we will pursue
the following Specific Aims: Aim 1. Establish a humanized-NTCP (huNTCP) hamster model for HBV
infection. We will use the validated CRISPR-mediated gene editing techniques developed by us in the hamster
to humanize the two codons encoding the key amino acid residues in the hamster NTCP protein required for
HBV infection. Aim 2. Establish acute and chronic infection in the huNTCP hamsters and characterize the
pathogenesis and humoral immune responses to HBV. Under this Aim, we will infect huNTCP hamsters to
establish acute and chronic HBV infections and carry out pathogenesis studies. We will also carry out studies to
characterize the humoral responses during acute and chronic infections. Aim 3. Test direct-acting antivirals
(DAAs), immunoregulators and epigenetic modifiers in suppressing HBV infection in the huNTCP
hamster model. We will test the utility of this immunocompetent huNTCP hamster model in assessing the
efficacies of a selected panel of anti-HBV drugs with different HBV-inhibiting mechanisms, including a direct
acting antiviral (DAA), tenofovir (TDF), an immunoregulator, IFNalpahcon-1, and an epigenetic modifier, MS436,
in suppressing chronic HBV infection. We envision that this novel hamster model will greatly facilitate the
development of new therapeutics that are needed to achieve a functional cure for HBV.

Public health relevance
Project Narrative Chronic hepatitis B virus (HBV) infection affects more than 296 million people globally and approximately 820,000 people die each year from HBV infection and related complications such as cirrhosis and hepatocellular carcinoma (HCC). One of the major impediments in developing a cure for HBV is the lack of immunocompetent animal models permissive to HBV infection. The goal of this project is to develop a novel hamster model to support the development of new therapies to cure HBV infection.